How myelin regulates vestibular circuit function and balance behaviors

SUMMARY/ABSTRACT
Loss of myelin, as seen in conditions like multiple sclerosis, frequently leads to balance issues. These dis-
ruptions in balance are attributed to the compromised function of neural circuits associated with the vestibu-
lar system. Despite the clinical significance of this problem, our understanding of how myelin loss affects the
functioning of these circuits remains limited. Consequently, there is a pressing need to elucidate the mecha-
nisms underlying the impact of myelin, its loss and restoration on circuit function. To address these questions,
I propose using zebrafish larvae as a model. They allow for in vivo observation of myelinated axons and func-
tional/behavioral testing. My preliminary data using a pharmacological hypomyelination model showed specific
changes in pitch sensitivity linked to a particular circuit, the vestibulospinal circuit. My aim is to understand the
role of myelin in behavior and circuit function, as well as the deficits caused by myelin loss and potential rescue
through remyelination.
In the K99 phase, I will (1) investigate changes in vestibulospinal circuit neuron responses to body tilts after
hypomyelination, (2) analyze postural and functional deficits after targeted demyelination, and (3) develop a
novel tool for circuit-specific myelin manipulations. These experiments will define the impact of demyelination
on vestibular processing and postural instability. Successful completion will provide functional characterization
of vestibular circuits and validate a selective myelin disruption tool. In the R00 phase, I will (1) explore mech-
anisms of neuronal and behavioral recovery after remyelination and (2) create conditional myelin inhibitors to
model circuit-specific incomplete remyelination. Achieving these goals will shed light on circuit-specific effects
of remyelination after loss.
My long-term goal is to run an independent laboratory using larval zebrafish to (1) understand the mechanisms
by which loss of myelin disrupts neural circuit function and behavior and (2) understand how remyelination
rescues behavioral and functional deficits. To achieve this, my lab will leverage the behavioral technologies I
have used in the first stage of my post-doctoral training, the functional imaging I will master in the K99 training
phase, and my previous training as a molecular and cellular glia -biologist. The proposed studies target an un-
met need: understanding the role of myelin in a circuit specific manner. This work is broadly significant as it ad-
vances our understanding of the relationship of myelin, circuit function and behavior with implications for novel
treatment approaches for demyelinating diseases.

Public health relevance
PROJECT NARRATIVE The proposed research will elucidate behavioral, cellular, and circuit mechanisms of de- and remyelination and establish a powerful new model to assay drugs that may increase remyelination and functional recovery. There- fore, the proposed research is relevant to public health and part of the NIH’s mission to develop scientific re- sources that will ensure the Nation’s capability to prevent and, one day, cure disease.